MEDICAL WRITING CONSULTING SERVICES

The NIH is seeking senior-level, industry-experienced drug discovery and development consultants with expertise in the following specific disciplines to provide leadership and technical guidance on drug discovery and development projects in HEAL and possibly other NIH neuroscience-focused drug discovery and development programs.

The purpose of this requirement is to procure consultant services to provide technical recommendations to the HEAL drug discovery and development programs in the area of Medical Writing.

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

Public health relevance
This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.